Advancing mosquito blood-feeding rate quantification using micro-CT imaging: an innovative tool for vector-borne disease transmission studies

Abstract
Mosquito-borne diseases impose significant burdens on global public health, with anthropogenic changes in
landscape, socio-economy, and climate further accelerating transmission. However, our ability to quantify the effects of
these socio-environmental changes on disease transmission remains limited, impairing our predictions of disease spread
and the development of effective intervention strategies. Current field studies primarily rely on vector abundance to assess
transmission risk, overlooking the critical role of human-mosquito contact. Mosquito biting rates, a key determinant of
pathogen transmission, are difficult to measure accurately in natural settings due to the lack of reliable methods. Thus,
despite its importance, field-derived data on mosquito biting rates are scarce, hampering our understanding of how socio-
environmental factors influence disease transmission. This study seeks to fill this gap by developing a novel methodology
using X-ray micro-computed tomography (micro-CT) to assess key tissue characteristics for quantifying mosquito blood-
feeding rates. Building upon a labor-intensive traditional histologic technique, our proof-of-concept study supported that
micro-CT imaging offers a non-destructive, high-resolution alternative capable of visualizing bloodmeal separation and
ovarian development in Aedes aegypti, a primary vector of many mosquito-borne diseases. By applying this innovative
technology, we aim to provide an efficient and scalable approach to quantifying mosquito biting rates more accurately. In
Specific Aim 1, we will optimize protocols for sample preparation, micro-CT scanning, and post-imaging processes to
balance image clarity and throughput, ensuring cost-effective application. In Specific Aim 2, we will develop image
standards and diagnostic keys to assess relevant mosquito midgut and ovarian tissue characteristics important for
determining blood-feeding rate, and validate their reliability through blinded validation studies. The adoption of micro-CT
imaging technology represents a significant advancement in vector-borne disease research. While micro-CT is well-
established for imaging insect morphology, its application to quantify mosquito blood-feeding rates is novel. This project
provides a much-needed improvement over traditional histology, simplifying sample preparation and enhancing imaging
precision, and will revolutionize how mosquito blood-feeding rates are measured across diverse environments. The 3D
imaging technology will also offer deeper insights into mosquito anatomy and physiology, including in blood-engorged
midguts—the critical juncture where pathogen infection occurs. The expected outputs include shared protocols, image
data, and diagnostic resources that will enable more accurate estimation of mosquito biting rates in the field. By bridging
the gap between field data and predictive models, we will enable more precise assessments of disease risk, particularly in
the face of rapid socio-environmental change. The results of this research will have far-reaching implications, enhancing
global disease prevention efforts and empowering researchers with the tools needed to combat mosquito-borne diseases
more effectively.

Public health relevance
Project Narrative Mosquito-borne diseases such as malaria, dengue, West Nile, chikungunya, and Zika continue to pose an escalating threat to global public health due to recent surges in transmission. This proposal seeks to develop a micro-CT- based imaging method to accurately quantify mosquito blood-feeding rates, a key factor driving disease transmission. Improving the precision of mosquito feeding rate measurements will lead to better predictions of disease risk and more effective strategies for pathogen transmission prevention and control.